Models of rodent facial musculature for the study of active tactile sensing

Project Summary:
The rodent vibrissal (whisker) system is one of the most widely-used models in neuroscience to study how
information about movement and touch are combined. During many exploratory behaviors, rats and mice
sweep their whiskers back and forth in a rapid, rhythmic motion called “whisking” to actively gather touch
information. Although whisking is rhythmic, rodents can also change how their whiskers move depending on
the desired sensory information, and on their particular behavior. Researchers are nearly able to begin to
“close-the-loop” between movement and touch for the whisker system, except for one critical gap: we do not
yet have a three dimensional (3D) model of rodent facial musculature. Without such a model, we cannot
identify how the rat changes its muscle activity to change whisker motion and acquire particular types of
sensory information. We cannot know which whisker motions are fixed via the biomechanics, versus which
motions the rat can actively control. We cannot fully understand the motor commands sent to the whisker
muscles. The central goal of this proposal is to develop three-dimensional (3D) models of rodent facial
musculature that close this gap. We will first use a novel combination of tactile profilometry, histology, MRI, and
CT-scans to quantify the anatomy of rodent facial muscles and the follicles that hold the whiskers. Using this
anatomy, we will then construct 3D biomechanical models of the whisker muscles and follicles to simulate the
motion of all whiskers. These models will be validated and tested in several different complementary software
systems, and then be used to test eleven specific predictions for the particular function of each whisker-related
muscle. Finally, we will integrate the 3D models of rodent facial muscles with existing models that describe the
sensory, tactile side of whisker motion. These combined muscle-sensory simulations will be directly compared
with active animal behavior. This work takes a step towards closing the loop between motor action and the
sensory data acquired, and helps disentangle the relative roles of biomechanics and neural control during
different types of whisking. The proposed work will inform all levels of study of whisker neural pathways, from
primary sensory neurons to sensory and motor cortical areas, to brainstem regions involved in controlling
whisker motions. More generally, whisking represents a unique window into how volitional control can
modulate or override centrally-patterned movement. The transition between varieties of rhythmic and non-
rhythmic movement has important implications for the coordination of sniffing, breathing, olfaction, chewing,
swallowing, and suckling, and the proposed work could thus shed light on the neuromechanical basis for some
pediatric and geriatric dysphagias.

Public health relevance
Project Narrative We often take for granted our ability to seamlessly combine movements of our limbs and hands with the sense of touch, yet neuroscientists do not yet have a good understanding of how this coordination is achieved. In the proposed work, we use the rat whisker system as a model to study how the muscles that allow movement, as well as the biomechanics of movement, guide the sense of touch. This work is important for two reasons: 1) it is one of the first examples of understanding the way the body and brain combine sensing and movement all the way from touch sensors to muscle control; and 2) it may help us understand why some infants and some elderly persons have trouble swallowing, chewing, and breathing.